UC San Diego Clinical and Translational Research Institute

Contact PD/PI: FIRESTEIN, GARY S
OVERALL PROJECT ABSTRACT
The UCSD Clinical and Translational Research Institute (CTRI) hub is located at the University of California,
San Diego (UCSD). This regional center includes three universities (UCSD, San Diego State University and
UC Riverside), 4 biomedical research institutes (Salk Institute, Sanford-Burnham-Prebys Medical Discovery
Institute, J. Craig Venter Institute and La Jolla Institute for Immunology), 3 academic hospitals (UCSD Medical
Center, VA San Diego Medical Center and Rady Children's Hospital), 2 community health centers (El Centro
Medical Center and Eisenhower Medical Center) and multiple community agencies. The CTSA program
encompasses 2 health sciences professional schools (Medicine, Pharmacy), 2 schools of public health (San
Diego State University and UCSD), 2 Master's programs in Clinical Research and Drug Discovery Sciences
and a new Translational Science Certificate. The program goals are to: 1) Develop an integrated education and
training program across the translational science spectrum; 2) Empower community-based partnerships and
team science while integrating stakeholders into translational research governance; 3) Diversify and enhance
biomedical informatics infrastructure to provide secure, confidential and inter-operative platforms that are
aligned with national CTSA standards; 4) Provide administrative infrastructure to manage and improve clinical
and translational research; and 5) Provide resources that enhance collaboration, encourage disruptive
innovation and support clinical investigation. The CTSA program, which is housed in the new Altman CTRI
building, will provide the resources to develop the discipline of clinical and translational research, improve
research quality and efficiency, assure a diverse workforce pipeline, and support a culture of collaboration and
team science. The UCSD CTRI will incorporate UC Riverside School of Medicine and San Diego State
University Schools of Nursing and Public Health into its KL2 program to increase the heterogeneity of
disciplines and background of trainees. The Center for Life Course Research will support investigation across
the lifespan and in special populations and support team science through a new Collaboration Core. We will
develop two new team science centers called the Device Acceleration Center and the Center for Excellence in
Translational Immunogenomics to facilitate engineer-clinician and basic scientist-clinician collaborations,
respectively. The UCSD CTRI will leverage its resources by collaborating with other CTSA hubs, including the
NCATS CTSA national centers and a consortium of University of California CTSA hubs.
Page 126
Project Summary/Abstract
Contact PD/PI: FIRESTEIN, GARY S
OVERALL

Public health relevance
PROJECT NARRATIVE The UCSD Clinical and Translational Research Institute (CTRI) will continue to support and transform clinical research by providing guidance and support from initial planning of research through data analysis and dissemination. It will provide an educational pipeline to train the next generation of clinical and translational scientists and involve the community in setting the direction and priorities of the organization. The CTRI will foster development of novel technologies that facilitate clinical research and support investigators by providing the services needed to conduct clinical research and improve health. Page 127 Project Narrative